Genetic Epidemiology of Hepatocellular Carcinoma in African Americans

Project Summary/Abstract
Over the past three decades, hepatocellular carcinoma (HCC) emerged as the fastest growing cancer in the U.S.
With cure being possible in less than 10% of patients and 5 year survival rates less than 20%, attention to HCC
prevention is paramount. Large racial/ethnic disparities exist in the incidence of HCC in the U.S. where the
incidence rates are now 2-fold higher in African Americans than non-Hispanic whites. Differences in prevalence
of established HCC risk factors do not fully explain the disproportionately high HCC burden in African Americans,
and clinical interventions and policies to close these racial gaps have been largely ineffective because
fundamental questions about how this disparity arises remain unanswered. We hypothesize that host genetic
factors may predict HCC risk in African Americans and may contribute to the racial disparities in HCC incidence.
Genome-wide association studies (GWAS) in European and Asian descent populations have been successful
in revealing common genetic risk alleles for HCC. However, germline genetics of HCC varies by the underlying
disease etiology and by genetic ancestry. To date, no HCC GWAS has been performed in African Americans. A
barrier to genetic studies of HCC in African Americans is the lack of comprehensive genetic, epidemiological and
environmental risk factor data from a large cohort of cases. We propose a GWAS of HCC in African Americans
using a proven state-wide (Texas) cancer patient contact study approach. In a case-control study, we will
investigate the relationship between common genetic variation genome-wide and the risk of HCC in African
Americans (Aim 1); these data will provide first insights into the germline genetics of HCC in an African ancestry
population. We will use independent GWAS data to validate our top hits and to perform cross-race comparisons
to assess the transferability of genetic findings across populations. It is plausible that host genetic factors may
also confer susceptibility to HCC risk among patients with cirrhosis, the precursor for HCC. Therefore, in Aim 2,
we will identify genetic risk factors for cirrhosis progression to HCC using two parallel case-control studies:
comparing cirrhosis patients with controls, and comparing HCC cases with cirrhosis patients. If variants associate
with HCC in the HCC versus control comparison (Aim 1) but not the cirrhosis versus control comparison (Aim 2),
we may also identify genetic risk factors associated with HCC in the absence of cirrhosis, a potentially growing
sub-population of HCC cases. Because early detection of HCC is critical, our last aim (Aim 3) will use information
on genetic and non-genetic risk factors to derive clinically applicable comprehensive prediction models for risk
stratification. This will be the largest study to date of HCC and cirrhosis in African Americans. Our comprehensive
evaluation of novel genetic markers underlying HCC risk in an unmatched cohort of African Americans with HCC
will have major translational implications for HCC prevention and early detection.

Public health relevance
Project Narrative Hepatocellular carcinoma (HCC) is one of the fastest growing causes of cancer-related deaths among Americans, and it disproportionately affects African Americans. Differences in prevalence of established HCC risk factors do not fully explain the high HCC burden in African Americans, and clinical interventions and policies to close these racial gaps have been largely ineffective because fundamental questions about how this disparity arises remain unanswered. Using a genome-wide association study approach, our research aims to identify and validate genetic factors that predispose to the development of HCC in African Americans and contribute to the racial disparities in HCC incidence.